Ethical Perspectives Towards Using Smart Contracts for Patient Consent and Data Protection of Digital Phenotype Data in Machine Learning Environments

PROJECT SUMMARY
Our parent project (NIH R01MH125958) is characteristic of a growing number of studies collecting highly gran-
ular and sensitive digital phenotyping (DP) data with great promise to advance science and healthcare. DP data,
in combination with artificial intelligence and machine learning (AI/ML) is poised to revolutionize clinical ap-
proaches to personalized medicine both within and outside of psychiatry. However, DP data also poses potential
risks to patients’ privacy and self-determination due to their growing capacity to reveal – and increasingly to
predict – emotional and behavioral states undetected by humans. Existing legal protections do not adequately
address novel features of the DP data ecosystem which enable applications (including monetization and ex-
change of DP data) that are not directly linked to patient benefit and potentially expose patients to risks that are
difficult to predict. The objective of this proposal is to identify practical, ethical and technical benefits, challenges
and incentives for implementing smart contracts: an emerging privacy-by-design technology with promise to
enhance patient control over future uses of their DP data. Our supplement brings together interdisciplinary ex-
pertise in bioethics, medical anthropology, decision science/behavioral economics and machine learning . Led
by an expert in qualitative and mixed methods, our team will conduct interviews to identify diverse stakeholders’
perceptions and technical understandings about potential benefits, challenges, and ethical considerations for
using smart contracts to implement patient data sharing preferences for DP data collected for psychiatric re-
search (Aim 1). Informed by Aim 1 findings and using behavioral economics insights, in Aim 2 we will model an
optimal “choice architecture” to incentivize diverse stakeholders’ engagement with smart contracts in ways that
are ethically justified and align with stakeholder interests. This contribution is significant because it will provide
knowledge critical to support collaborations that modernize patient protections within a growing DP data ecosys-
tem characterized by complex social, economic, technical and legal relations. Our approach is innovative in that
it treats the DP data ecosystem as an ethnographic space comprised of relations between and among human
actors as well as technologies emerging in parallel but in the absence of an incentivizing patient -centered frame-
work. The work is feasible because our team of established investigators have expertise in ethical , technical,
behavioral and policy issues related to DP data use and a track record of success working together on large
collaborative projects addressing ethical issues related to emerging technologies including AI/ML.

Public health relevance
PROJECT NARRATIVE Smart contracts constitute a novel privacy-by-design tool and critical pivot point around which a larger system of technologies and policies may be symbiotically developed to help protect sensitive digital phenotyping (DP) data, guided by ethical concerns for individual patient rights and future impacts. This research will systematically identify ethical and technical challenges as well key opportunities for near-term collaboration toward the responsible development of patient-led smart contracts to enhance transparency, patient control and self- determination over how DP data is shared. This study is thus responsive to the vision of NIH to foster collaborations that can modernize biomedical data ecosystems using the latest data science technologies.